Testing the role of belief updating in persecutory delusions

Persecutory delusions, or the strongly held belief that others intend me harm, are distressing and disabling
transdiagnostic symptoms. They are the most common manifestation of delusions in psychotic disorders,
present in over 70% of cases, and exist at the extreme end of the paranoia spectrum. Persecutory delusions
are a leading cause of suicidal ideation and hospitalization amongst individuals with schizophrenia, yet
effective, sustainable treatments remain limited. One potential route towards developing new treatments is
identification of cognitive processes that directly contribute their maintenance. Predictive coding is a prominent
mechanistic account of delusions based in the process of belief updating, which describes how we learn about
the world and develop new beliefs. Development of adaptive, rational beliefs depends on an accurate
understanding of the volatility of the environment, or how frequently the probabilities underlying the
environment change. Over-estimation of volatility (i.e. inferring that the environment has changed when it has
not) drives the formation of new beliefs that are based on faulty inference. There is growing support that
aspects of volatility-related belief updating contribute to paranoia and persecutory delusions specifically.
Longitudinal data from the PI’s K23 newly demonstrate that volatility-related belief updating is abnormal in
delusional patients with schizophrenia, normalizes with symptom improvement, and is associated with
activation in specific brain regions. Yet, these data remain limited by their correlational nature. Randomized
controlled trials are the gold standard of causal inference testing, drawing more definitive conclusions about
mechanism. Therefore, to push this research forward and directly test the belief updating model of delusions,
we will recruit 120 individuals with a schizophrenia-spectrum disorder endorsing a persistent persecutory
delusion and randomize them to receive either formulation-driven cognitive-behavioral therapy for persecutory
delusions (CBTp), which has been previously shown to reduce delusion severity, or an active control therapy
(befriending). We will then test whether modification of persecutory delusion severity using psychotherapy
impacts belief updating at the level of behavior (Aim 1) and neurobiology (Aim 2), investigating specific brain
circuits underlying distinct volatility parameters. Our ultimate goal is to leverage the insights gained into new,
mechanistically informed treatments for persecutory delusions and paranoia, translating computational
neuroscience to clinical applications.

Public health relevance
Persecutory delusions are extremely common in schizophrenia and cause significant disability and distress. Contemporary mechanistic models suggest that altered belief updating is a cognitive process underlying persecutory delusions, yet rigorous tests of this are needed. We propose to use a clinical trials design to determine whether behavioral and neurobiological aspects of belief updating change with intervention, with the goal of generating knowledge for translation into new treatments.